NCI NCTN-Network Lead Academic Participating Site at UPMC Hillman Cancer Center

Abstract:
This supplement will be used to support additional faculty time to devote to increasing patient
enrollment to LAPS studies. A new faculty member has joined the medical oncology breast program (Dr.
Julia Foldi). A portion of her salary will be supported by this supplement. In addition, two additional
faculty (Dr. Haider Mahdi and Dr. Melissa Burgess) will obtain additional salary support from this
supplement. In addition, due to travel constraints over the past couple years, some funding from this
supplement will be used to support travel for UPMC faculty and study team members to attend national
conferences such as NRG and Alliance conferences.

Public health relevance
Narrative: The main goal of this supplement is to increase accrual to LAPS trials at UPMC. With the addition of Dr. Julia Foldi to the Hillman Comprehensive Cancer Centers' (HCCC) medical oncology breast program, we anticipate a significant uptick in clinical trial accruals to breast protocols. The two components being supported by this supplement include faculty salary support for continued and expanded patient enrollment to LAPS trials as well as travel budget support.